Developing proteomics pipelines to improve depth, throughput, and accuracy

ABSTRACT
Mass spectrometry (MS)-based proteomics is emerging as an essential tool for addressing important biological
questions. Although many advancements have been made in the field over several decades, efforts are still
needed with respect to sample preparation and data acquisition processes. In this research proposal, I will
address challenges that limit throughput, depth, and accuracy in proteome-wide protein abundance, post
translational modification (PTM), and cysteine profiling. Technological advancements in MS instrumentation
steadily improve sensitivity, resolution, and speed of mass-to-charge measurements. Here, I will develop
platforms to establish and optimize new MS-based proteomics technologies using these advances to address
the challenges listed above. Leveraging state-of-the-art technologies, I will design high-throughput MS-based
proteomics pipelines to profile proteomes and PTMs with unprecedented depth. The focus will be on sample
preparation and data acquisition, both of which are continuously evolving. As the scale in both the number and
the breadth of proteomics experiments increases, sample preparation becomes the key bottleneck. As such, a
greater emphasis is necessary to streamline and automate all possible aspects of sample preparation to
improve throughput and efficiency. As an example of the pipeline development process, I will test the
hypothesis that select kinase inhibitors induce general and cell-specific alterations in the proteome,
phosphoproteome, as well as protein inter- and/or intra-molecular changes that can be inferred by differential
cysteine accessibility. The workflows will be established in a 96-well format with 8 cell lines and 11 kinase
inhibitors (plus a control) after both 4hr and 24hr of treatment and will be performed in triplicate. Both isobaric
tagging and data independent acquisition strategies will be investigated. In addition, I will also continue my
efforts to ensure accurate quantification and thorough benchmarking of instrument performance with an
updated quality control standard for isobaric labeling experiments and an associated web-based, automated
database searching application. Ultimately, I aim to provide the community with innovative pipelines for high-
throughout, accurate, and deep proteome, PTM, and cysteine profiling, while producing datasets (of my own
and of collaborators) that are informative, biologically relevant, and readily accessible. The newly established
pipelines may be adapted by the community to explore further various aspects for their own studies and can be
used as templates to design experiments in line with their own research interests. For trainees, optimization
projects are pedagogically ideal as they stress an understanding of the first principles behind a specific
workflow and typically result in publishable data. In summary, the proposal that I have outlined above will result
in a sustainable research program that can develop cutting-edge proteomics pipelines, while simultaneously
address a wide range of biological questions for a scientific community which has varied research interests and
diverse backgrounds.

Public health relevance
NARRATIVE Mass spectrometry (MS)-based proteomics has become an essential tool for addressing important biological questions, yet significant room for improvement persists throughout the sample preparation and data acquisition process. This research program seeks to develop and optimize MS-based proteomics technologies along every step of the workflow, to enable more efficient, accurate, and comprehensive characterization of proteomes, post-translational modifications, and accessible cysteines. We will provide the community with a platform to establish pipelines to address diverse and specific research questions that will advance our understanding of biological processes and related diseases.